New York Obesity Research Center

PROJECT SUMMARY/ABSTRACT
The New York Obesity Nutrition Research Center (NYNORC) has as its primary aim to convene and support -
by its Core Services, Pilot & Feasibility and Enrichment programs - funded investigators at Columbia University
and the Albert Einstein College of Medicine studying obesity. The themes for this Center include: the etiology,
pathophysiology and complications of obesity; treatment strategies; the physiology of weight regulation and
nutrient use; development of new tools and strategies for the study of nutrition and obesity; and the training and
development of scientists to study nutrition and obesity. A particular strength of the NYNORC, by design, is an
explicit commitment to the promotion of multidisciplinary research that integrates basic observations relating to
nutritional, metabolic and behavioral biology, with the application of these insights to clinical approaches to the
prevention and treatment of obesity. The size and breadth of our base has provided a strong basis for
collaborations and productivity. During the current cycle, the research base has grown from 109 to 115 funded
members. Currently, NYNORC members were PIs on 206 obesity-related grants totaling $60M/annum in
direct costs: 166 grants from NIH totaling $48M/annum ($13M NIDDK) and 40 foundations and
pharmaceutical entities supported obesity-related grants totaling $11M/annum. NYNORC Members are
PIs of 12 NIH training grants, 14 P30 and P50 program projects, the CTSA at Columbia, and mentors of 10 K
series and 4 F31 graduate awards. These efforts are supported by our three Biomedical Research Cores:
Human Phenotyping, Animal Phenotyping and Molecular Biology/Molecular Genetics. Since the last submission,
the Cores have provided ~40,000 services to 115 members, including ~8464 services provided by the Human
Phenotyping Core, 10,231 services from the Animal Phenotyping Core and >20,000 service requests by the
Molecular Genetics/Molecular Biology Core. The research base is also supported by a highly successful Pilot
& Feasibility Program – subsidized by the sponsoring institutions - that awarded $1.2M to 13
investigators since the last submission and 3 new awards to begin this summer. In addition, through the
Naomi Berrie Diabetes Center programs in Frontiers in Diabetes Research, the Russell Berrie Initiative in the
Neurobiology of Obesity and the recently inaugurated Preliminary Translational Research Program, the
NYNORC has access to an additional ~$2M in annual funds to support innovative studies related to the
pathogenesis and treatment of obesity. The NYNORC is a dynamic enterprise that has strong institutional
support permitting it to evolve and thrive as it fosters novel and collaborative science in the study of obesity. This
evolution is apparent in the role of members of the NYNORC in creating intellectual and physical resources for
addressing basic and translational research approaches to COVID-19 epidemic.

Public health relevance
PROJECT NARRATIVE The NYNORC, the oldest NIH obesity research center, operates in support of $60M per year of peer-reviewed obesity-related research. Through closely integrated, outstanding core facilities, pilot projects, enrichment and clinical activities, the center has made major contributions to basic understanding and applied approaches to the problem of obesity. Our goal remains to expand the knowledge base relating to the causes, complications and treatments of obesity.